High-throughput microPET/CT at UCSF Preclinical Imaging Core

Project Summary (Abstract)
We request this high-end instrumentation (HEI) S10 grant to acquire a replacement microPET/CT scanner for
the existing Siemens Inveon that was purchased in 2007. There is a great urgency to imminently replace this
scanner as the reliability of the scanner has begun to decline significantly especially when the scanner
manufacturer discontinued its support of this instrument. The scanner has reached the end of its useful lifetime
(14+ years of continuous operation). There is a significant demand for use of the scanner to support a large
number of projects that are funded mostly by NIH; thus, combined with the great urgency, we propose to acquire
a replacement scanner as soon as possible. There is no other microPET/CT system within the campus core
facilities. After a comprehensive comparative study of commercially available scanners, we propose to acquire
nanoScan microPET/CT from Mediso USA with GNEXT from Sofie as a backup choice. These two systems have
comparable specifications and have been the choice for replacing Siemens Inveon at many other preclinical
imaging centers. Both of these systems have depth-of-interaction (DOI) correction technologies that provide
more uniform spatial resolution within the field of view than non-DOI detector-based systems like our existing
Inveon system. Most members of the technical team including the PI on this S10 grant are the ones who have
been supporting microPET/CT operation and research at our institution since 2007, and we have a great degree
of technical expertise in small animal imaging using microPET/CT. This expertise includes physics and
instrumentation of microPET/CT, PET radiochemistry, small animal imaging procedures, and complex data
analysis. At the time of this S10 grant submission, we identified 9 Major and 4 minor users with 30 projects that
have specific components that benefit from microPET/CT. The administration of microPET/CT will take
advantage of existing technical expertise, local advisory committee, and institutional laboratory animal research
resource. The financial administration is through the departmental finance team as well as the institutional
research resource program that supports the institution-wide core management software solution. The
institutional commitment, in addition to administrative support, includes a significant matching fund against the
purchase of the instrument, which was obtained on a highly competitive basis, recognizing our need for
microPET/CT replacement over several other resources requested at the same time. The departmental support
includes financial backup for recharge operations such as an annual subsidy in case there is a shortfall of
revenue over expenses, the upkeep of the infrastructure, funding for pilot projects, and salary support for faculty
with the roles of core administration. Finally, one of many impacts of this S10 grant will be to potentially lower
the user fee for our microPET/CT users, which could lead to higher quality data generation with improved
statistical significance by a large number of animal studies afforded by saving from microPET/CT usage.

Public health relevance
Project Narrative (Relevance) The UCSF Preclinical Imaging Core requests the High-End Instrumentation (HEI) S10 grant to replace the outdated, and out-of-service Siemens Inveon microPET/CT scanner to continue a broad spectrum of clinically relevant research projects that will benefit from the proposed replacement instrument, Mediso nanoScan microPET/CT.